Characterization of spinal circuits underlying motor synergy function

Abstract:
The CNS performs extremely complex computations with remarkable efficiency. This is exemplified by the
ability to seamlessly execute motor behaviors that necessitate the coordination of multiple muscle groups
controlling joints with many degrees of freedom. It is thought that one strategy to simplify motor computations
is to adopt a circuit organization that links combinations of motor pools into functional units called “synergies”
or “primitives”. Thus, the circuit elements that underlie motor synergies are thought to represent the basic
building blocks for orchestrating the neural control of routine motor behaviors. Elegant stimulation and recording
experiments from labs working with amphibians, rodents, and primates have found evidence for motor synergy
circuits within the spinal cord. The major questions addressed in this grant are: (a) what is the underlying
cellular and connectivity organization of lumbar spinal motor synergy circuits, (b) what neuronal subtypes
comprise these circuits, and (c) what intrinsic and extrinsic factors shape the formation of these circuits?
The laboratory has used trans-synaptic neuronal tracing, optogenetics, and molecular screens to identify a
heterogenous (Satb1+, Satb2+, Tcfap2b+, Tcf4+) population of interconnected excitatory and inhibitory pre-
motor interneurons within lamina V of the lumbar spinal cord. Based on their properties these lamina V cells
are generically referred to as motor synergy encoders (MSE). The hypothesize is that the MSE cell network
comprises a major computational node for motor control within the spinal cord. These cells receive inputs from
the cortex and sensory neurons such as those that relay proprioceptive information. Thus, MSE neurons are
well positioned to mediate coordinated muscle activation patterns arising from command centers for volitional
movement as well as reflex pathways activated by sensory feedback locally within the spinal cord.
The aims of this grant are designed to unravel the wiring and cellular constituents within motor synergy
circuits, and to examine how these circuits form during embryonic development and early postnatal life. Aim 1
will create a cellular atlas and connectivity map of MSE neurons. This will define whether the molecular
heterogeneity of MSE neurons corresponds to separate motor pool circuit-modules or physiologically-different
classes of neurons used for controlling all motor pools. Aim 2 will define the pattern of propriospinal feedback
from muscles onto MSE neurons. Here the goal is to establish whether the MSE circuit is based on simple
labeled line pathways or has a more complex input-output relationship. Aim 3 will use transcription factor
knockouts to determine whether hardwired intrinsic genetic programs establish the MSE circuitry. Aim 4 will
test whether the functional MSE network arises from activity dependent feedback from proprioceptive sensory
neurons. Taken together, these aims will provide a detailed molecular-cellular understanding of a critical node
within the local spinal system for computing and coordinating motor activation patterns. These findings may
help target motor circuits using genetics and/or neural activity to facilitate recovery from spinal cord injury.

Public health relevance
Project Narrative: The spinal cord contains local circuitry that drives coordinated patterns of motor pool activity to produce motor behaviors. In this grant the investigators will identify the cellular constituents of this circuitry, characterize the wiring diagram, and study how the neural circuitry arises. These experiments could provide new insight to understand how to overcome spinal cord injuries using motor learning and targeted stimulation to enhance the function of these neural pathways.